Hypoglossal neuropathy in the pathogenesis of radiation associated dysphagia (hRAD)

ABSTRACT/SUMMARY
Radiation-associated dysphagia (RAD) is a leading driver of QOL and a potentially life-threatening survivorship
issue, afflicting more than half of patients treated with curative radiotherapy (RT) for oropharyngeal cancers
(OPC). Aspirators are almost 5-times more likely to develop pneumonia than non-aspirators, and pneumonia
confers a 42% increased risk of mortality among cancer survivors. Radiation fibrosis has long been considered
the primary driver of RAD, but the investigators’ preliminary work points to late cranial neuropathy as a major
contributor to truly severe forms of delayed or late-RAD. Cranial neuropathy (denervation) is clinically detected
a median of 5 to 8 years after RT after a “quiet period” of functional recovery. There is currently no early indicator
for this injury. Delayed identification means that muscle atrophy and profound functional injury is typically present
at the time of diagnosis, limiting therapeutic potential. The long-term goal of this work is to reduce dysphagia
burden through mechanistically and technically nimble surveillance algorithms as a major step toward
personalized management. Our central hypothesis is that subclinical hypoglossal neuropathy is prevalent and
associates with severity of RAD early in HNC survivorship and novel non-invasive lingual high density surface
electromyography (HDSEMG) is feasible for quantitative functional surveillance. The objective of the proposed
study is to analyze gold-standard needle EMG and experimental HDSEMG of the tongue as an optional procedure
in an existing large-scale OPC cohort and two clinical trial datasets that capture robust longitudinal swallowing
outcomes data to: 1) estimate prevalence of hypoglossal neuropathy along continuum of survivorship (diagnosis,
early, and late) after oropharyngeal radiation (Aim 1); 2) correlate EMG-detected hypoglossal neuropathy and
swallowing function over time before and after oropharyngeal radiation (Aim 2); and 3) examine feasibility of
HDSEMG as a rapid, non-invasive quantitative screening method for hypoglossal neuropathy (Aim 3). Building
upon the highly curated functional data from the MD Anderson OPC Patient-Reported Outcomes/Function
(PROF) Core and investigators’ track record of non-invasive signal measurement in the tongue, we are uniquely
positioned to accomplish these complementary aims. This high risk/high reward work could lead to practice-
change. We expect the outcomes to provide proof of concept that subclinical hypoglossal neuropathy is a
mechanism underlying RAD that can be measured with a novel, non-invasive device. Thus, providing data to
support a novel and measurable target (subclinical hypoglossal neuropathy) underlying a hugely impactful and
potentially deadly common toxicity –RAD– in a fast growing, young OPC survivor population.

Public health relevance
PROJECT NARRATIVE The incidence of highly curable head and neck cancers is rapidly rising and there are more long-term survivors than ever. Radiation treatment is very commonly given at doses sufficient to cause crippling late cranial neuropathy (nerve dysfunction) and dysphagia (difficulty swallowing) that can progress to the point that it results in a lifelong feeding tube or death from aspiration pneumonia even after cancer is cured. This application seeks to understand how abnormal nerve function in the tongue may be present and measured long before it is evident in clinic, hopefully to provide an earlier therapy target to help swallowing function before irreversible damage is done.